Comprehensive reference atlas construction, geolocation and data integration for HuBMAP HIVE [5 of 5]

Abstract
The Human BioMolecular Atlas Program (HuBMAP) is redefining our understanding of the human body by
recovering multi-scale tissue organization--anatomical, histological, and molecular--at unprecedented resolution,
through computational integration of diverse experimental measurements. The current HuBMAP HIVE has led
the development of a human common coordinate framework (CCF); constructed molecularly and spatially
resolved reference maps of human tissues; developed mapping frameworks for the interpretation of new
datasets; and coordinated extensive collaborative activities both within HuBMAP and with the broader
community. In Y5-8, we will construct a Human Reference Atlas (HRA), establishing the HuBMAP Portal as the
“go-to” resource for human tissue reference maps and multimodal single-cell data. We propose a Mapping
Center to build upon our progress in Y1-4, and achieve these goals. Our center represents a synergistic
collaboration between three labs, Dr. Rahul Satija (NYGC/NYU), Dr. John Marioni (EMBL/EBI), and Dr. Jean
Fan (JHU). Our Mapping Center proposes to lead a series of key tasks for HuBMAP. These include the
construction of single-cell reference maps for 30 human tissues, where maps will be constructed by harmonizing
a wide diversity of multimodal single-cell technologies. We also propose to lead the development of mapping
tools that will enable users in the community to upload their own datasets and map them to HuBMAP references.
Importantly, these tools will not be limited to single-cell RNA sequencing datasets, but will be extended to process
datasets that measure chromatin accessibility, chromatin modifications, DNA methylation, intracellular and
surface protein levels, and metabolic profiles as well. We also propose to lead the development of statistical
methods to perform comparative analysis of multiple datasets. This will enable key use-cases for users both
within and outside of HuBMAP, including the ability to perform comparative analysis of healthy vs. diseased
tissue. We expect our MC to work together with and lead the HubMAP community to a deeper understanding of
the functional organization of human tissues and, and to explore how molecular state, environment, and
anatomical location, affect cellular identity and behavior.

Public health relevance
Public health statement: We propose a Mapping Center as part of the Human Biomolecular Atlas Project (HuBMAP), that will assist in the construction of a HuBMAP Human Reference Atlas. The reference atlas will represent a full “parts list” of the human body and it will describe their multi-scale spatial and molecular organization. Our work aims to deepen our understanding of human cell types and human anatomy, and to establish a map of the healthy human body that will represent a valuable reference for understanding and interpreting disease.